Comparative Organismal Energetics Core

Project Summary (Comparative Organismal Energetics Core)
The central theme of the UAB/IU Nathan Shock Center (NSC) concerns how energy flux at the level of the cell,
tissue, or whole animal affects health and longevity. The Comparative Organismal Energetics Core (Organismal
Core) addresses the biology of aging by specializing in measuring whole animal energy flux in a range of species
under a variety of environmental, dietary, and behavioral conditions. The “variety of conditions” point is critical to
understanding the utility of this Core as changes in those conditions can have dramatic impact in health and
energy flux. The Organismal Core has also pioneered assessment of body composition in living flies and
zebrafish as well as assessment of metabolic rate in individual fruit flies and worms. We particularly emphasize
that the assays described herein can be performed under a range of environmental, behavioral, and dietary
conditions as requested by investigators. This Core provides specialized expertise in the development and
utilization of methodologies, state-of-the-art instrumentation, and the selection of animal models to facilitate
understanding the contribution of energetics to biological aging, including how nutritional, genetic, and
biochemical interventions that impact aging research. The Organismal Core can precisely measure energy
acquisition, storage, and utilization in a variety of animal models of healthspan and lifespan. This Core now offers
expanded comparative energetics services for health- and life-span modes ranging from single-celled yeast to
invertebrates, thereby addressing the overall theme of the UAB/IU Shock Center. The Core will provide expertise
in the area of energetics and body composition in multiple animal models of aging. It will also provide state-of-the-
art instrumentation and methodology for the determination of in vivo body composition and energy balance across
the lifespan. It contains state-of-the-art instrumentation and methodologies for evaluating healthspan–associated
behaviors or model organisms of aging and will develop
new methodologies for assessing energetics/body composition as necessary. Finally, this Core will provide
education and training on procedures and pitfalls in comparative organismal energetics.